SLEAP: a Sleep ancillary to the Long-term Effectiveness of the Anti-obesity medication Phentermine trial

PROJECT SUMMARY
Sleep is a crucial, modifiable determinant of energy balance and body weight regulation but is rarely
considered in treatment strategies for obesity. The current standard of care for obesity treatment is lifestyle-
behavior therapy (LBT) to promote improvements in diet and physical activity; however, changes in these
behaviors are difficult to sustain. Anti-obesity medications (AOM) have emerged as a promising modality to
augment LBT. Phentermine is a low-cost sympathomimetic agent accounting for 75% of all AOM prescription
fills. While phentermine can inhibit food intake by increasing norepinephrine levels in hypothalamic nuclei, this
activation of the sympathetic nervous system also promotes arousal and disrupts sleep. Insomnia is a reported
side effect of phentermine monotherapy; however, empirical data are limited. Systematic investigation of the
impact of phentermine on sleep is needed given the key role of sleep in determining energy balance and body
weight: suboptimal sleep leads to obesogenic eating behaviors and predicts poorer weight loss outcomes in
response to treatment. Given the stimulant properties of phentermine and robust relationship between sleep
and energy balance behaviors, we postulate that sleep will influence the treatment response to phentermine
monotherapy and that the magnitude of phentermine’s effect on sleep will vary with the timing of
administration. To address these knowledge gaps and test our working model, we plan to leverage the “Long-
term Effectiveness of the Anti-obesity medication Phentermine” (LEAP) trial, a placebo-controlled randomized
trial funded by the NHLBI to test the impact on body weight of phentermine monotherapy as an adjunct to an
LBT program over 24 mo in 1,000 adults with overweight and obesity. The proposed ancillary study plans to
assess free-living sleep at baseline, 6, 12, and 24 mo visits via objective measures (actigraphy and home
sleep testing) in up to 580 participants (290/arm). Our aims are 3-fold: (1) to test the impact of phentermine vs.
placebo on objective measures of sleep during the treatment period; (2) to assess the influence of timing of
treatment administration during the day on nocturnal sleep; (3) to evaluate whether differences in sleep during
the intervention period influence treatment effects on change in body weight, diet, and physical activity at 24
mo. We anticipate that phentermine will adversely affect sleep relative to placebo, but that adverse effects will
be attenuated among those completing their dosing earlier, relative to later, in the day. Further, given the role
of sleep in weight management, we hypothesize that differences in sleep in response to treatment will
moderate the efficacy of phentermine in producing long-term improvements in body weight and energy balance
behaviors. Results of this ancillary will provide novel insight into the role of sleep in the effect of phentermine
on weight loss and help to identify individuals who might benefit most from this low-cost AOM. Consequently,
findings will guide obesity treatment recommendations to optimize sleep for maximal efficacy.

Public health relevance
PROJECT NARRATIVE Pharmacotherapy offers promise as an obesity treatment by limiting external drivers of overeating, promoting adherence to healthful lifestyle behaviors involved in energy balance regulation. Phentermine, the most- prescribed anti-obesity medication, is a sympathetic nervous system stimulant, yet its effects on sleep, an established behavioral determinant of diet, activity, and body weight, have not been evaluated. We propose to formally test the impact of phentermine vs. placebo on sleep and explore whether sleep during the intervention period influences the efficacy of phentermine in improving body weight, diet, and physical activity.